Reverse-engineering precision liver cancer chemoprevention

Identification of clinically relevant cancer chemoprevention targets has been challenging. Our multidisciplinary
team (Precision Liver Cancer Prevention Consortium) will employ an innovative reverse-engineering approach,
starting from transcriptome analysis of archived clinical specimens with long-term clinical follow-up, then
moving to multifold experimental verification of only clinically well-validated targets, to elucidate
chemoprevention targets with the highest likelihood of successful clinical application. With this approach, we
could successfully identify liver cancer risk signatures and chemoprevention dugs, leading to a clinical trial
(NCT02273362). To achieve our long-term goal of establishing clinically applicable chemoprevention strategies,
here we aim to elucidate molecular dysregulation underlying carcinogenic milieu in livers affected with non-
alcoholic steatohepatitis (NASH), the fastest rising liver cancer etiology, as clues to refined chemoprevention
targets, drugs, and biomarker assays, which are expected to enable personalized patient management and
more cost-effective liver cancer chemoprevention clinical trials, and lead to revolutionary improvement of
patient prognosis and establishment of a new paradigm, reverse-engineering precision cancer prevention.
Aim 1. Computationally-targeted screening of liver cancer chemoprevention agents. Candidate liver
cancer chemopreventive compounds will be computationally prioritized, and screened together with LPA
pathway inhibitor library in liver cancer risk signature-inducible cell system for the gene signature reversal. For
selected compounds in the screen, mechanisms of action will be interrogated by gain- or loss-of-function
assessment in the cell system.
Aim 2. Functional validation of candidate liver cancer chemoprevention agents. In vivo liver cancer
chemopreventive effect of the candidate agents will be validated in a diet-induced fibrotic/carcinogenic rat
model mimicking global human cirrhosis transcriptome. Human relevance of the agents will be evaluated in
organotypic ex vivo culture of clinical fibrotic liver tissues (n=30). To determine target cell type(s) and
mechanisms of action for the agents, major hepatic cell types will be isolated from the rats, and transcriptome
profiling will be performed to assess liver cancer risk signature member genes, the inferred target genes for the
compounds, and related molecular pathways. Human fibrotic/cirrhotic NASH livers will be similarly profiled for
cell type-specific transcriptomic dysregulation to verify that the modulated genes are relevant in human.
Aim 3. Development of tissue- and serum-based liver cancer risk biomarker assays. Liver tissue-based
cancer risk signatures will be implemented in clinically applicable tissue- (NanoString) and serum- (Luminex)
based assays, and evaluated for technical validity and capability to predict future cancer risk in a cohort of 200
NASH patients with paired serum and liver tissue specimens as well as completed long-term clinical
observation for cancer development.

Public health relevance
Liver cancer chemoprevention will substantially improve the dismal patient prognosis, although still impossible. We have developed Precision Liver Cancer Prevention Consortium, and will employ an innovative multidisciplinary reverse-engineering approach to simultaneously identify liver cancer chemoprevention biomarkers, targets, and drugs ready for subsequent clinical assessment and deployment, with special focus on non-alcoholic steatohepatitis, the fastest rising etiology of liver cancer globally.